Development-Associated Linear Chromosome Segregation in Streptomyces

Project Summary
Streptomyces are ubiquitous filamentous sporulating soil bacteria, important in the environment
because they degrade and recycle the nutrients locked in many recalcitrant natural polymers in the
soil (e.g., cellulose and chitin) and produce the majority of a wide range of biologically active
compounds that are used extensively in human and veterinary medicine (e.g., antibiotic, antiviral,
anticancer, antitumor, antifungal, immunosuppressant and anthelmintic pharmaceuticals).
Streptomyces are also well known as one of the major producers of the compounds that give soil its
characteristic earthy odor. These organisms have large linear genomes. Little is known about the
architecture of the linear chromosome within the Streptomyces spore and the mechanisms which
govern its development-associated genome segregation and nucleoid condensation during spore
formation are poorly understood. The ultimate goal from the proposed basic research is to have a
better understanding of the novel cellular processes of these distinctive organisms of tremendous
medical importance.
The unusual mycelial life cycle and linear structure of the Streptomyces genome are likely to require
some unique solutions to the fundamental problems of genome segregation and condensation. The
first specific aim of the proposal is to characterize a novel small coiled-coil protein that is exclusive to
this group of organisms. A genetic approach was used to provide evidence that this protein is
involved in development-associated genome segregation. A proximity-labeling approach, with a
promiscuous biotin ligase fusion, is being used to identify proteins that interact with this novel protein
in vivo. Alanine-scanning and random PCR-directed mutageneses are being used to identify residues
important for protein-protein interaction with one known binding partner. The second specific aim is to
characterize type VII secretion system ATPase proteins. In addition to their functions in protein
secretion, the ATPase proteins are moonlighting in development-associated segregation and nucleoid
condensation. A genetic approach will be used to dissect the first type VII secretion ATPase to
identify the region(s) needed for genome segregation. A genetic approach will also be used to
determine the parts of both type VII secretion ATPases to identify the regions necessary for correct
nucleoid condensation in the spore. Mutants lacking genes encoding both type VII secretion ATPases
have genomes organized against the spore periphery (doughnut-shaped) instead of being condensed
as an ellipsoid nucleoid in the center of the spore.

Public health relevance
Relevance We wish to understand how DNA is segregated and packaged in the special filamentous organisms that produce the majority of biologically active compounds used to treat bacterial infection and cancer. These organisms are major producers of the compounds that we all rely on for our health and quality of life. Basic knowledge of fundamental cell functions of these organisms may lead to better production of known and novel compounds, which may lower the cost of buying medicines.